3D Fourier Imaging System for High Throughput Analyses of Cancer Organoids

Challenges. Tumor spheroids (and organoids) have become an instrumental tool in cancer research. These
self-organized, three-dimensional (3D) systems can recapitulate phenotypic and functional traits of patient
tumors in vivo, thereby serving as a powerful testing bed to study tumor heterogeneity, interactions with the
environment (e.g., extracellular matrix), and responses to external stimuli (e.g., chemotherapy, radiation). Fully
harnessing spheroids' utility, however, is stymied by lack of high-throughput analysis methods. Conventional
bright-ﬁeld microscopy, although widely used to monitor spheroids in culture, fails to capture detailed cellular
organizations; advanced ﬂuorescent microscopy can resolve individual cells, but its imaging throughput is
restricted by the small ﬁeld-of-view (FOV) and the scanning mechanisms involved. Innovations. We aim to
advance a new volumetric imaging microscope (VIM) for single cell analyses in tumor spheroids. Speciﬁcally,
we will explore integrating Fourier ptychographic microscopy (FPM) with diffraction tomography. FPM is based
on a spatially coded-illumination technique, collecting low resolution image sequences while changing the
position of a point-light source. These images are then numerically combined in the Fourier space, which
allows FPM to achieve both wide ﬁeld-of-view and high spatial resolution in 2D images. We reason that full 3D
microscopic images can be recovered by accounting for optical diffraction during the numerical reconstruction.
Approaches. Aim 1. System development. We will build a VIM system featuring: i) a new numerical algorithm
to reconstruct 3D volumetric images; ii) a new light-illumination strategy to speed up the data acquisition; iii)
microﬂuidic cartridges optimized for spheroid culture and drug treatment; and iv) multicolor imaging capacity for
molecular detection. The complete VIM will resolve individual cells constituting a spheroid at high resolution
(lateral, 0.4 µm; axial, 1 µm) in a large imaging volume. Aim 2. Treatment monitoring with tumor spheroids. We
will test VIM's practical utility: VIM-enabled spheroid imaging will reveal earlier than bulk imaging whether a
spheroid is responsive or resistance to drug treatment. To generate a tumor model, we will use primary GBM
cells from patients. GBM spheroids will be grown and treated with drug (temozolomide) inside microﬂuidic
cartridges. We will use the VIM to monitor how single cells change their phenotypes under treatment, and
correlate these changes with treatment outcomes. Impact. The VIM will be a transformative tool for cancer
research, empowering researchers with rich data sets and substantially advanced analytics. Immediate
applications include better monitoring of anticancer drug responses in 3D cell culture, analyzing cellular
heterogeneity, and prospectively detecting cellular fate under various physiological conditions. These
outcomes will strengthen the clinical and scientiﬁc utility of tumor spheroids in cancer research.

Public health relevance
We will advance a new, volumetric imaging microscope (VIM) for high-resolution, 3-dimensional (3D) tomography. Speciﬁcally, we will integrate computational optics, microﬂuidics, and machine learning approaches; it will make the VIM capable of resolving a large number of individual cells in 3D culture. We will use the VIM to analyze how single cells in a tumor spheroid change their phenotypes under drug treatment.